Administrative Services

Abstract ? Administrative Services The Administrative Services Unit provides key components that maintain and operate the infrastructure of the Center. It is comprised of 4 distinct subunits: Business Office, Grants Administration, Human Resources and Center Resources. Each of these units provides a distinct service to the TNPRC. The Business Office is responsible for developing the annual budget for TNPRC, including the P51 budget, reviewing all internal transactions, generating monthly financial reports for use at all levels at the TNPRC to help ensure budget goals are maintained. Grants administration is responsible for reviewing all grant proposals prior to submissions, helping ensure budgets are adhered to and providing instruction if budget adjustments are needed. Human Resources is responsible for new employee orientation, processing staff changes regarding salary and effort allocation, and ensuring that semi-annual effort certification is completed accurately and timely. Center Resources is responsible for twice weekly courier trips to New Orleans and surrounding areas for package delivery and pick-up, daily mail distribution, and receiving of packages from outside vendors.